Reparative effect of juvenile factors in aging and injury

Aging and injury are among the major global health problems and death due to injury increases sharply with age. As hemorrhage accounts for almost half of all trauma-related deaths, there is a need to develop methods to reduce the adverse effects of aging on injury to facilitate healthy living. In this proposal, our objective is to establish that circulatory factors of juvenile origin can improve outcome following injury in the mature and aged animals. Studies show that mesenchymal stem cells (MSC) and extracellular vesicles (EVs) from MSC culture supernatant are protective following tissue injuries. The experiments proposed in this project are based upon our finding that following hemorrhagic shock in a mouse model (hemorrhagic shock injury; HI) juvenile mice have a survival advantage compared to adult mice. Our studies also indicate that EVs derived from MSC culture supernatants and from the plasma of young mice can improve survival in adult mice. Based upon these data our hypothesis is that plasma factors from juvenile animals can restore mitochondrial function, alleviate oxidative stress and reduce organ dysfunction and death in mature and old mice subjected to HI. We will test our hypothesis by determining the protective effect of juvenile mice-derived EVs in mature and old mice and identify potential mechanisms by which juvenile plasma factors exert salutary effect in mature and aged mice following HI. Our goal is to develop methods to revitalize the aging system by identifying molecular factors involved in maturational development. We will use a combination of cell biological, biochemical and genomic tools and techniques to test the hypothesis. We expect that our studies will result in the identification of juvenile protective factors that can improve outcome following hemorrhagic shock. The proposed research is relevant to the part of NIH’s mission pertaining to developing fundamental knowledge to potentially help reduce the burdens of human disease. The outcome of this research will be significant because the fundamental knowledge gained from this study is expected to advance methods to promote healthy living.

Public health relevance
Aging and injury are among the major global health problems and death due to injury increases sharply with age. Hemorrhage accounts for almost half of trauma-related deaths. In this proposal we seek to identify endogenous juvenile factors that can reduce the adverse influence of aging on outcome following hemorrhagic shock.